Stress-Induced Signaling in Aortopathy

In 2018, roughly 74% of people reported psychological stress within the past year. Chronic psychological stress
has been associated with increased risk for developing cardiovascular disease and hypertension, however the
exact mechanism linking the two is unknown. Patients with post-traumatic stress disorder (PTSD), a disorder of
extreme stress, have higher heart rates and blood pressures as well as an increased prevalence of resistant
hypertension. Resistant hypertension is likely neurogenically derived as stress-induced changes in blood
pressure are mediated, in part, by an amygdala-hypothalamic pathway contributing to sympathetic
overactivation. This pathway is regulated by inhibitory GABA-ergic circuits. Elevations in blood pressure have
been shown to influence extracellular matrix (ECM) remodeling leading to disruption of aortic wall homeostasis
and increased vascular fibrosis predisposing to aortic pathology such as aortic aneurysms. Allopregnanolone is
a neurosteroid that functions as a positive allosteric modulator of the GABAA receptor and has been shown to
reverse neurogenic hypertension and treat PTSD symptoms in both animal and human studies. Our lab has
demonstrated that mice with generalized anxiety and neurogenic hypertension exhibit elevated medial collagen
and collagen cross-linking, and decreased thoracic aortic compliance. Additionally, these mice have an
accelerated rate of thoracic aortic aneurysm progression demonstrating a predisposition to vascular pathology.
Furthermore, our lab has developed a PTSD-like mouse model that exhibits higher blood pressure that is renin
independent, elevated medial collagen, and increased thoracic aortic stiffness. Importantly, PTSD mice that
underwent thoracic aortic aneurysm induction displayed an accelerated rate of aneurysm development. Thus,
we hypothesize that stress-dependent hypertension alters homeostatic ECM remodeling which can
accelerate vascular pathology. This hypothesis will be tested using two mouse models, a generalized anxiety
model and a PTSD model. Aim 1 will investigate the determinants of stress-induced ECM remodeling by
examining the role of sympathetic overactivation in neurogenic hypertension, the mechanism of TGF-b signaling
driving stress-induced ECM remodeling, and novel signaling pathways directing stress-induced ECM remodeling
through bulk RNA sequencing. Aim 2 will demonstrate that allopregnanolone, a novel therapeutic, can suppress
stress-induced neurogenic hypertension and acceleration of aortic pathology. Following allopregnanolone
administration to both mouse models, attenuation of sympathetic overactivation, stress-induced ECM
remodeling, and thoracic aortic aneurysm acceleration will be determined. Preliminary data has demonstrated
the expression of the GABAA receptor in the thoracic aorta. Thus, local effects of allopregnanolone on contractility
and relaxation will be examined. Results from this proposal will increase our understanding of the link between
stress and aortopathy as well as the development of a novel therapeutic. In addition, this fellowship will provide
me with training in cutting-edge techniques that will support my development as a surgeon-scientist.

Public health relevance
PROJECT NARRATIVE Cardiac and vascular pathologies have been associated with chronic psychological stress, however the exact underlying mechanisms have yet to be discovered. This proposal aims to understand how stress-induced neurogenic hypertension may contribute to extracellular matrix remodeling and tests a potential therapeutic to reverse its effects. Completion of this proposal will provide new mechanistic insights into the interconnection of the cardiovascular and nervous systems in the setting of psychological stress, and in particular PTSD, and may lead to the advancement of novel therapeutics to prevent stress associated aortopathy.